Role of Ptpn2 in B cells during development of autoimmunity

Project Summary
This R03 proposal is to follow-up on recent findings from my SERCA K01 award, which focuses on
elucidating the role of the type 1 diabetes (T1D) PTPN2 risk allele in loss of B cell anergy. Previously B cells
bearing antigen receptors with high affinity for insulin were found only in the anergic B cell compartment of
healthy individuals. Importantly, these cells leave this compartment in a proportion of first-degree relatives
(FDRs), and in all autoantibody positive pre-diabetics and recent onset T1D individuals. Departure of these
autoreactive anergic B cells in FDRs was shown to be associated with the high risk non-HLA allele, PTPN2
(rs1893217). PTPN2 has been previously shown to be a negative regulator of T cell signaling, but has not been
studied in B cells. Recently we demonstrated that mice that lack Ptpn2 specifically in their B cells
(Mb1Cre.Ptpn2fl/fl.C57BL/6) have a decrease in anergic B cells, similar to our findings in humans, an increase in
autoimmune associated B cells (ABCs), increase in production of autoreactive antibodies, and a hyperresponsive
phenotype. Despite these findings, these mice did not develop overt autoimmunity, likely driven by the fact these
mice are on the autoimmune resistant genetic background, C57BL/6. Hence, in this study we aim to determine
the effect of B cell specific deletion of Ptpn2 in the NOD mouse, which develops spontaneous diabetes by about
20 weeks of age. Specifically, we aim to study whether B cell deletion of Ptpn2 increases the rate and penetrance
of diabetes incidence, the effect on frequency and activation status of insulin-reactive and non-reactive B cells,
as well as its effect on B cell antigen presentation to T cells and the differentiation of pathogenic T cells. The
potential impact of these studies will lie in understanding how risk alleles conspire to undermine maintenance of
immune tolerance to autoantigens in T1D.

Public health relevance
Project Narrative In this application we propose to study the mechanisms by which the type 1 diabetes PTPN2 risk-allele contributes to loss of B cell tolerance during the pathogenesis of disease using a mouse model for diabetes. The overarching goal of these studies is to better understand how genetic factors contribute to type 1 diabetes by changing the activity of autoreactive B cells in hopes of translating findings into novel therapeutic targets to treat the disease.